Stanford Women's Reproductive Health Research Career Development Program

PROJECT SUMMARY
Overview: The principal mission of the Women’s Reproductive Health Research at Stanford (WRHRS)
Program is to provide state-of-the-art, mentored, multidisciplinary research career development for outstanding
junior clinician-scientists who will impact and improve women’s reproductive health. Thirty-six Faculty Mentors
and 7 Advisory Committee members (5 internal; 2 external) representing 3 Schools, 15 Departments, and 8
Institutes at Stanford will collaborate to mentor junior faculty-level clinician-investigators (“WRHRS Scholars”)
to acquire the skills and experience needed to transition into productive, independent physician-scientists able
to sustain viable careers and mentor future generations. Training Program and Candidate Pool: The WRHRS
Program cultivates excellence in basic, clinical, translational, data science, and epidemiology research to
address the national shortage of qualified investigators in women’s reproductive health. The Program includes
a structured training plan of sufficient duration to achieve independence; individualized didactic education
based on skills, competencies, and needs; extensive team-based mentoring; hands-on research; and
protected time with immersion in a vibrant research community. Stanford has accomplished, dedicated, and
well-funded mentors, innovative curriculum, and extensive infrastructure in place to prepare WRHRS Scholars
for research independence. Each Scholar will have a multidisciplinary mentor team as well as access to
abundant resources and the rigorous research infrastructure of the OB/GYN Department and the University.
We have an excellent pipeline of internal Scholar candidates and the means to attract candidates nationally.
Two WRHRS Scholars will be supported each year of the 5-year program. Duration of support for each Scholar
will average 2-4 years thereby providing training for 4 Scholars. Scholars will pursue one of six Research
Focus Areas in which Stanford demonstrates exceptional strength and breadth: 1) Maternal-Child Health &
Epidemiology, 2) Reproductive Biology, 3) Gynecologic Health Across the Lifespan, 4) Gynecologic
Oncology, 5) Innovative Technology, and 6) Social Medicine. Scholars will develop essential academic
skills and a portfolio of research projects to propel their transition to independence. Research progress and
career outcomes of Scholars are evaluated on an ongoing basis by Faculty Mentors, Program leadership, and
the Advisory Committee. Innovation and Impact: Our Program will catalyze growth of women’s reproductive
health research in a vibrant, innovative, and collaborative environment. WRHRS is synergistic with many
Stanford School of Medicine programs focused on innovation in precision medicine, global health, data
science, artificial intelligence, and biotechnical innovation. Our cadre of WRHRS Scholars will be well poised to
improve the reproductive health of women over the lifespan.

Public health relevance
PROJECT NARRATIVE The comprehensive Women’s Reproductive Health Research at Stanford offers OB/GYN junior clinician-investigators an individually tailored program of didactic research methods and mentored career development to bridge the transition to academic independence. The primary goal is to develop highly trained, creative, and productive independent investigators in reproductive science to address the increasing opportunities in this field. Having this program embedded in Stanford’s rich culture of innovation and collaboration provides an exceptional environment to empower the next generation of independent investigators who will advance reproductive health for all.